Applied Research Component

PROJECT SUMMARY
This application is a competing renewal of the "Vervet Research Colony as a Biomedical Resource" (VRC,
P40-OD010965). The VRC is the only NIH-funded biomedical research resource for US-born vervet/African
green monkeys (AGM; Chlorocebus aethiops sabaeus or Chlorocebus sabaeus) and has been continuously
funded since 2005. The VRC serves a wide range of local, regional and national investigators by providing
animals, biological samples, data, consultation and training pertaining to the use of vervets/AGMs as multi-
categorical, translational models of human disease. The VRC has facilitated critical translational research
across a wide variety of disciplines, including: a) the development of the vervet as an emerging nonhuman
primate model of aging and Alzheimer's disease risk with a focus on the assessment of physical function,
amyloid burden, neurodegenerative disease biomarkers, and synaptic degeneration; b) investigations into the
efficacy and enhancement of vaccines for infectious diseases such as neonatal influenza, respiratory syncytial
virus, dengue fever, and COVID-19; c) studies focused on the etiology and health consequences of diabetes,
metabolic disease and obesity; d) the development of novel, non-invasive biomedical imaging methodologies;
and e) the expansion of the critical genetic resources available for vervets. The aims of the VRC resource are
to: 1) provide the scientific community with access to animals, biological samples, data and expertise to
facilitate the use of vervets for a wide-range of biomedical research; 2) to provide exceptional training
opportunities for veterinarians and researchers interested in using vervets for translational research, and to
serve as a platform for community and scientific outreach to foster better understanding of the use of
nonhuman primates in biomedical research; and 3) to enhance the resource by engaging in applied research
focused on continuing phenotypic and genetic characterization, and the development of the vervet as a
translational model in novel research areas. The VRC has served as a critical component of the Wake Forest
Clinical and Translational Science Award (CTSA), which helps facilitate the utilization of the VRC resource
across the larger CTSA network. The VRC can take full advantage of a wide-range of existing research
facilities within the Wake Forest University School of Medicine, including multi-modal imaging capabilities,
veterinary and pathology expertise, and genetic and analytic resources.

Public health relevance
PROJECT NARRATIVE The Vervet Research Colony (VRC) is the only NIH-supported biomedical research resource dedicated to providing animals, biological samples, data, consultation, and training on the use of vervets/African green monkeys (AGM) for translational research. The vervet/AGM is a valuable nonhuman primate model for studies of aging and Alzheimer's disease, infectious disease, neuroscience, cardiometabolic disorders, and genetics. Continued phenotypic and genetic characterization of the vervet, along with the maintenance and expansion of the VRC data archive and biorepository, are all critical for helping meet the needs of the scientific community.